Ubiquitin and Metabolite Signaling

The original Project Summary/Abstract document has not changed as a result of the proposed supplement
activities.

Public health relevance
The original Project Narrative document has not changed as a result of the proposed supplement activities.